Task A19: Determination of the Extent of Bacillus anthracis Spore Persistence in New Zealand White Rabbits after Prophylactic Treatment

This contract provides for the development and standardization of small animal models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.